Infectious Disease Training in Clinical Investigation

Abstract
This T32 training program, which is closely associated with the University of Minnesota adult
Infectious Diseases physician fellowship program, is designed to prepare MD, MD/PhD, and
other post- doctoral trainees for successful careers as clinical, epidemiological, and translational
investigators in Infectious Diseases. There is a focus on emerging / reemerging infections and
global health. The program has 4 post-doctoral slots per year and on average accepts 2 new
trainees annually, usually following an initial year of clinical Infectious Diseases training.
Trainees undergo a 2-to-3 year intensive research experience, either locally or at an affiliated
international site, supervised by one or more of 27 expert faculty mentors who represent diverse
disciplines and departments within the Medical School, School of Public Health, College of
Pharmacy, and College of Veterinary Medicine.
Trainees participate in didactics (including in Responsible Conduct of Research,
biostatistics, and grant-writing), a journal club, and a research conference series, plus local,
regional, and national Infectious Diseases conferences. Trainees can obtain an MS-Clinical
Research degree or an MPH in Epidemiology, can take individual courses within the School of
Public Health, and can take a Global Health course that qualifies them to sit for the American
Society of Tropical Medicine & Hygiene (ASTMH) Certificate examination in Tropical Medicine
(CTropMed). Oversight of trainee progress is by the Program Director and a Scholarship
Oversight Committee, which meets semiannually with each trainee. Trainee selection and
program governance are by the Program Director and a Steering / Selection Committee.
Continuous program improvement is guided by feedback from current and former trainees, the
Scholarship Oversight Committee, and an External Advisory Committee.
Of the 32 total T32 trainees to date, 17 (53%) were women, 5 (16%) were under-
represented minorities, and 2 (6%) have had disabilities requiring accommodations. Five fellows
still are in training, and of the program's 27 graduates, 12 (44%) now have research-intensive
careers with ≥75% research effort; another 8 (30%) have research-related academic careers.
Overall, 7 (26%) have been awarded NIH K Career Development Award (CDAs), VA CDAs, or a
Foundation CDA, and another 4 (15%) have K08 or K23 applications currently submitted, 5
(18.5%) have R01, U01, VA Merit, or VA Cooperative Studies Program awards as the PI.
Program graduates have disseminated to 7 states, mostly in the upper Midwest.

Public health relevance
Project Narrative This T32 training program is designed to train new clinical, epidemiological, and translational infectious disease investigators, who are needed to discover better ways to diagnose, treat, and prevent serious emerging and re-emerging infections and other Global Health threats such as HIV/AIDS, influenza, meningitis, and antimicrobial-resistant infections. The program draws on multiple schools and colleges within the University of Minnesota, plus a Global Health course and an international site, to provide post-doctoral trainees – primarily Infectious Disease physicians – with the advanced skills needed for a successful career in infectious diseases research.